Animal Core C

CORE SUMMARY The animal core will support all five projects of the current application by producing mice ready for experiments. Following consultations with project leaders regarding needs and breeding strategies, experimental mice and controls of the desired genotypes, ages, sexes and genetic backgrounds will be produced in sufficient quantity and within the desired time frame. Simple, robust procedures will be implemented at every stage to avoid errors and ensure genotyping accuracy. Mice will be genotyped at weaning, before being used as breeders, and after sacrifice at the end of experiments. Genotyping results will be scrutinized for quality and checked for consistency to avoid errors. Investigators will be notified when mice matching the desired criteria are ready. Breeding will be adjusted to match usage, thereby maintaining efficiency and minimizing cost.

Public health relevance
CORE NARRATIVE In spite of the publication of the sequence of the human genome at the turn of the century, much remains unknown about the regulation and function of the majority of these genes and their gene products. Investigation of the mouse genome has recently become an essential tool to unravel its human counterpart, thanks to its similar size and complexity. The present animal core will play a small part in this exploration by providing mouse models with well-defined genetic alterations to a group of biomedical researchers who will push the limits of our understanding of human health and disease.